Mechanisms underlying the variation in rate and levels of gingival inflammatory responses among the human population

Abstract
The goal of this research is to provide a roadmap to maintain periodontal health by understanding the
mechanisms which underlie the variation in inflammatory responses within the human population. Ultimately,
this information will be translated to individualized preventive and treatment regimens based on host response
phenotype. Periodontitis is one of the most prevalent non-communicable diseases in adults worldwide and a
major public health concern. According to the latest World Workshop in Periodontics there is immense potential
in studying gingivitis, an antecedent reversible disease state, as a means of primary prevention of periodontitis.
Healthy periodontal tissue exists in a homeostatic relationship with its accompanying oral microbiome. In most
individuals, this relationship results in a combination of host and microbial derived immune components that
produce an active inflammatory surveillance protective state. This is termed healthy homeostasis. Disruptions of
this healthy homeostatic state occur during episodes of both experimental and natural gingivitis, which is defined
as reversible inflammation of the gingiva. The ability to induce a reversible inflammatory state in humans has
provided a unique foundation to examine microbial-host interactions that dictate periodontal health and disease
via the human Experimental Gingivitis (EG) model. We will capitalize on our previous work with the highly
translational human experimental gingivitis model where we have identified three distinct clinical response
phenotypes, which behave differently to bacterial-driven inflammation. We will use these clinical phenotypes as
a foundation to explore the variability in the human inflammatory response. Specifically, we will determine the
contributions of host components and microbial ecological succession patterns to the observed variations among
responder types. The approach for this proposed research is to determine the bacterial and host processes in
stages of health through disease using advanced parallel multi-omic measurements of both bacteria and host
components coupled with ex vivo and in vitro mechanistic studies to determine the host and associated microbial
functions that determine the variation in host responses. We will employ a comprehensive combination of
functional meta-omics in parallel (DNA and RNA 16S sequencing, metagenomics, metabolomics, custom
multiplex Immunoassay of host mediator panels) along with complementary cultivation approaches for
hypothesis testing. We anticipate there will be an immediate benefit from our proposed detailed investigations in
terms of the comprehensive multi-omic datasets we will generate and make available – enabling responder types
to be identified and further characterized across studies. In the longer term, this fundamental mechanistic work
has direct clinical and therapeutic value by identifying potential critical targets during disease initiation and
development within each of the different response types that can translate to personalized treatment and
intervention strategies.

Public health relevance
Project Narrative The focus of this fundamental mechanistic project is to determine the microbial and host factors underlying variations in gingival inflammatory responses across the human population. Ultimately this basic information may provide the basis to guide treatments based on host response type.